Vanderbilt Alzheimer's Disease Research Center

VANDERBILT ALZHEIMER’S DISEASE RESEARCH CENTER – OVERALL PROJECT SUMMARY
We aim to establish the Vanderbilt Alzheimer’s Disease Research Center (VADRC) as a world-class
interdisciplinary center in Nashville, Tennessee. With high regional burden of Alzheimer’s disease (AD) and
related dementias (ADRD) as well as vascular risk factors, there is a pressing need to understand the
complexities underlying the intersection between vascular risk and ADRD. Vascular risk factors, the majority of
which are modifiable, are linked to ADRD risk and highly prevalent in our region, especially within the Black
and African American community. The VADRC’s mission is to characterize how vascular burden intersects with
ADRD pathogenesis, manifestation, prevention, and treatment at the cellular, systems biological, and
population levels. This effort will capitalize on the scientific strengths of our campus-wide investigators,
expansive and collaborative institutional resources, and foundational work completed over the last several
years. The Administrative Core will serve as the hub for all local ADRD research activities and coordinate and
integrate all Center interactions and collaborations. The Outreach, Recruitment, and Engagement Core will
build upon existing community partnerships to bring awareness of ADRD and relevant vascular risk factors to
the community. The Outreach, Recruitment, and Engagement Core team will recruit participants with a
vascular risk profile reflective of our local community into our Clinical Core alongside a specific focus on
outreach in the Black and African American community. The Clinical Core will enroll, deeply phenotype, and
annually follow 400 participants, capturing clinical, neuropsychological, cardiac imaging, neuroimaging, and
biofluid data in collaboration with the Biomarker Core. The Neuropathology Core will obtain post-mortem brains
and biofluids from participants, allowing for complete post-mortem characterization of ADRD and vascular
pathologies. Our Data Management and Statistical Core will ensure all data collected is properly stored in an
integrated informatics infrastructure, is shared with national repositories, and is readily accessible to other
investigators via our web-based data sharing platform. Finally, the VADRC will foster professional development
for the next generation of ADRD clinicians, scientists, and leaders, with a particular focus on supporting early
career faculty scholars through the Research Education Component. The VADRC is exceptionally well
positioned to become the first center of its kind in Tennessee and serve a growing population suffering from
ADRD.

Public health relevance
NARRATIVE With the incidence of dementia dramatically rising and its high co-occurrence with vascular disease being increasingly recognized, there is an urgent need to characterize and ultimately modify the pathways through which vascular risk, dysfunction, and disease intersect with Alzheimer’s disease. The Vanderbilt Alzheimer’s Disease Research Center will advance investigations into the contributions of vascular burden on Alzheimer’s disease at the population, systems biological, and cellular levels. Outcomes will advance knowledge and transform current prevention and intervention approaches to Alzheimer’s disease and related dementias.